A Small-Molecule Inhibitor of the Terminal Steps for Intracrine Androgen Synthesis in Advanced Prostate Cancer

? DESCRIPTION (provided by applicant): Androgen deprivation therapy (ADT) produces remission in advanced prostate cancer (CaP). However, CaP invariably recurs as castration-resistant/recurrent CaP (CRPC) and causes death. Tissue levels of testosterone (T) and dihydrotestosterone (DHT), which is the most potent androgen, decrease acutely after ADT. Once tissue homeostasis occurs, CRPC tissue T levels remain similar to androgen-stimulated CaP and benign prostate due to intratumoral androgen biosynthesis. Tissue levels of DHT, though reduced, remain sufficient to activate the androgen receptor (AR). The inhibition of enzymes critical in the final steps in T and DHT synthesis via backdoor pathways may reduce androgen levels more effectively than ADT. In the primary backdoor pathway to DHT synthesis, adrenal progestagens are 5α-reduced and converge on 5α-androstane-3α,17β-diol (DIOL), a direct precursor that is converted to DHT by at least 4 enzymes. A secondary backdoor pathway centers on androstenedione (ASD), an important adrenal androgen, which is 5α-reduced to androstanedione. Androstanedione is further metabolized to DHT by an enzyme that also converts ASD directly to T. All 5 of the key 3α-oxidoreductases in the primary and secondary pathways share a common catalytic site but otherwise are structurally unrelated. The goal of the proposed studies is to identify and inhibit the enzymes immediately proximal to intratumoral T and DHT synthesis. Our approach contrasts to inhibition of earlier enzymes, such as CYP17A1, that lie distant from the final steps in T and DHT synthesis, with agents such as abiraterone that have extended overall CRPC patient survival by only several months. The central hypothesis is that a small-molecule inhibitor of the catalytic site shared by the five 3α-oxidoreductases will decrease T and DHT metabolism through the frontdoor and backdoor pathways. The hypothesis will be tested in 3 specific aims: Aim 1 Identify a candidate inhibitor against the catalytic site shared by the five 3α-oxidoreductases; Aim 2 Synthesize and test re-designed candidate inhibitors and conduct PK/PD and toxicity studies to produce a lead compound inhibitor of the five 3α-oxidoreductases; and Aim 3 Determine whether the inhibitor of the 3α-oxidoreductases decreases tissue T and DHT levels and impairs CRPC growth. Successful completion of the proposed studies should produce an inhibitor of the five 3α-oxidoreductases that is ready for final preclinical testing prior to clinical evaluation as a bettr abiraterone to reduce the death rate from advanced CaP.

Public health relevance
PUBLIC HEALTH RELEVANCE: Androgen deprivation therapy causes remission of advanced prostate cancer, but prostate cancer recurs through biosynthesis of potent testicular androgens from weak adrenal androgens. Our prior research led to the development, FDA approval and use of abiraterone that extended survival an average of 3.9 months by blocking an enzyme early in the pathway for production of testicular androgens. The proposed research is relevant to public health because it seeks to develop a small-molecule inhibitor of enzymes that catalyze the final step for production of testicular androgens, a blockade that should be more difficult to overcome than the more proximal effect of abiraterone. Remissions will be much longer as a result of this translational research designed to reduce testicular androgens and meet the NIH's mission pertinent to reducing the burdens of human cancer.